Investigation Into the Progression of MASLD to MASH and HCC

Metabolic dysfunction-associated steatotic liver disease (MASLD) (formerly known as nonalcoholic fatty liver
disease) is the most common cause of liver disease. The potentially severe consequences of MASLD include
cirrhosis, liver failure, need for liver transplant to survive, or hepatocellular carcinoma (HCC). The proportion of
Alaska Native and American Indian (AN/AI) Tribal members with MASLD is higher than in other communities.
Many people with MASLD are unaware of the disease’s long-term severe consequences or possible
reversibility in the early stage of the disease with lifestyle modifications that can prevent these consequences.
Metabolic dysfunction-associated steatohepatitis (MASH) is a more advanced form of MASLD, which is
accompanied by liver inflammation and scarring. A critical barrier to HCC prevention is identifying who is most
likely to develop MASH. Why some people progress to MASH is not fully understood, yet genetic factors are
associated with susceptibility to MASLD and MASH.
To further the mission of NIH, this study will increase the knowledge available regarding liver disease caused
by MASLD, MASH, and HCC, and utilize the gained information to improve the health and well-being of people
with these liver diseases in an effort to reduce the burden of HCC through secondary prevention of MASLD,
cirrhosis, and MASH, and to identify risk factors associated with progression of MASLD to MASH, cirrhosis and
HCC.